Molecular mechanisms of intra- and inter-cellular fatty acid trafficking

ABSTRACT
The biological hallmarks of aging have outlined multiple cellular and molecular processes that
contribute to aging. The hallmarks of aging include genomic instability; telomere attrition;
epigenetic alterations; loss of proteostasis; deregulated nutrient sensing; mitochondrial
dysfunction; cellular senescence; stem cell exhaustion; and altered intercellular communication.
These processes have been studied primarily in isolation from each other. However, many of
these processes span multiple cellular organelles or occur at the intersection between
organelles. We will use multispectral imaging to systematically investigate the morphology and
dynamics of six organelles simultaneously in live cells, as a method for imaging organelle
communication in relation to the hallmarks of aging. The organelles we will image include
endoplasmic reticulum, Golgi, lysosomes, mitochondria, peroxisomes, and lipid droplets. In aim
1, we will quantify organelle number, size, shape, speed, contacts with other organelles, and
distribution (the “organelle signature”), in multiple cell types at baseline. In aim 2, we will test
how organelle morphodynamics change during replicative aging. Together, these studies will
identify novel forms of organelle communication impacting the hallmarks of aging.

Public health relevance
PROJECT NARRATIVE Aging involves changes in the morphology, dynamics, and function of subcellular compartments, together termed morphodynamics. We will use multicolor live-cell imaging to visualize organelle morphodynamics in different cell types at baseline, and in a model of replicative aging. These studies will identify novel forms of organelle communication that underlie the hallmarks of aging, in health and disease.